Administrative Core

Administrative Core Project Summary / Abstract.
The Montana Clinical and Translational Research Center (Montana CTRC) will be led by an experienced
Administrative Core, and will work closely with the other Cores and Partner Organizations in building clinical
and translational (C&T) research. The Administrative Core will provide overall program and financial
management support to the Center. We will also implement a clear communication strategy across our Cores
and Partner Organizations through an efficient meeting schedule of the Executive, Steering, and External
Advisory Committees. Adding to the innovation of the Administrative Core is the C&T Mini-Grant Program to
support C&T researchers, as well as the mobile laboratory which can be used for data collection and
community outreach. Finally, we will utilize a comprehensive evaluation plan that consists of a mixed method
design. Through four Aims, we will test the overall hypothesis that a strong Administrative Core will lead to an
overall successful CTR-D program, while significantly building C&T research capacity in our rural and
underserved region. Our four Aims are: Aim 1) Provide an administrative infrastructure that facilitates the
development of clinical and translational research capacity, Aim 2) Implement effective strategies that facilitate
clear communication among the research investigators, Cores, committees, and Partner Organizations, Aim 3)
Provide innovative C&T support opportunities for CTRC researchers, and 4) Coordinate a comprehensive
evaluation program that assesses the needs of CTRC Cores and quantifies the success of the Montana CTRC.